CTSA Predoctoral T32 at Virginia Commonwealth University

PROJECT SUMMARY
The Translational Biomedical Sciences (TBS) CTSA Pre-doctoral T32 Program at Virginia Commonwealth
University (VCU) will provide trainees with in-depth topic expertise as well as crucial, non-discipline specific
knowledge, skills, and abilities to advance clinical and translational science research. TBS trainees will engage
in research experiences that provide a strong foundation in the mechanistic paradigms of disease pathology as
well as practice more contemporary skills such as team science, community engagement, and research
dissemination and implementation. Specifically, the TBS Program will 1) implement a novel interdisciplinary
mentoring approach with mentors who bring varied perspectives to the trainees’ research and career
development; 2) develop trainees knowledgeable about translational science who are proficient in study design
and conduct, data analysis, and publishing in accordance with best regulatory and ethical practices; 3) cultivate
trainees’ career development skills to prepare them to be productive biomedical researchers; and 4) connect
trainees with collaborators from across VCU as well as from other universities and with community
stakeholders to encourage interdisciplinary, scientifically rigorous, and clinically-relevant research. Building on
VCU’s extensive array of educational programs supporting underrepresented minority (URM) students,
interdisciplinary research programs committed to tackling diseases most burdensome to its catchment area of
Black/African-American communities, and diverse cohort of research mentors, the TBS Program will prioritize
the selection and training of predoctoral trainees belonging to URM groups (women, racial/ethnic minorities,
individuals from disadvantaged backgrounds, and individuals with disabilities). In doing so, the program will
intentionally promote workforce diversity to achieve health equity. The TBS Program will be co-directed by
three, highly-regarded translational researchers with leadership roles in clinical and translational research
education at VCU and housed within the Wright Regional Center for Clinical and Translational Science to
provide trainees with a breadth of training and career development opportunities as well as exposure to a
transdisciplinary, collaborative, and translational research environment. A cadre of mentors comprised of select
faculty from 15 different departments at VCU whose research addresses all stages of the translational
spectrum as well as Translational/Community advisers will create a fertile training environment that
encourages the development of researchers who are confident working with a variety of collaborators. During
the funding period, two highly-qualified trainees will be appointed to the TBS Program annually (total of 10
trainees over the 5-year funding period). In summary, the TBS Program will provide a comprehensive
educational experience that prepares a diverse group of trainees for successful, independent research careers
in the broad area of translational science as well as equips them with the skills to work across disciplines and
with stakeholders to design, disseminate, and implement their research.

Public health relevance
PROJECT NARRATIVE Taking discoveries in the laboratory and using them to improve human health requires researchers specifically trained to work collaboratively with other scientists as well as with patients, caregivers, clinicians, and other healthcare stakeholders. Knowing diversity enhances research training environments and is necessary to address the most complex, translational problems, Virginia Commonwealth University’s Translational Biomedical Sciences (TBS) Predoctoral Training Program will give special attention to including program trainees from backgrounds underrepresented in the biomedical sciences. It is within this context that the TBS Program will train a diverse group of scientists with specific knowledge, skills, and abilities to conduct research that will have a meaningful impact on human health.